Mechanisms underlying endothelin mediated neurodegeneration in glaucoma

Project Summary:
The endothelin (ET) system of vasoactive peptides (comprising of ET-1, ET-2 and ET-3) and their G protein
coupled receptors (ETA and ETB receptors) have been found to be elevated in animal models of glaucoma.
Corroborative findings from several laboratories have demonstrated that ET-1 acting through both vascular and
cellular mechanisms produces neurodegenerative effects in glaucoma. ET-1 mediates these effect through
activation of the ETA and ETB receptors, leading to optic nerve degeneration and retinal ganglion cell death. These
findings bring up exciting possibilities for neuroprotection by using agents that block endothelin receptors.
However, the mechanisms by which endothelin receptor activation contributes to neurodegeneration in glaucoma
is poorly understood. Preliminary data included in this application indicates that a reduction in mitophagy is a key
event that occurs during IOP elevation in Brown Norway rats, as well as following treatment of RGCs with ET-1.
Novel mechanisms involved in ET-1 mediated decline in autophagy will be addressed in the proposal with the
following specific aims: Specific Aim 1: Determine if endothelin-1 (ET-1) acting through its receptors decreases
mitophagy in retinal ganglion cells. Specific Aim 2: Elucidate mechanisms contributing to decreased mitophagy
in retinal ganglion cells following IOP elevation in rodents. Specific Aim 3: Determine the mitochondrial
mechanisms contributing to the neuroprotective effects of endothelin receptor antagonists in IOP elevated rats.
The innovative aspects of the project include an in-depth assessment of ET-1 mediated autophagy and high-
resolution imaging studies, using super-resolution and 2-photon confocal microscopy, to understand the
dynamics of mitophagy (a quality control mechanism for mitochondria) which is compromised in glaucoma. The
project will also generate possibilities for pharmacological interventions to block endothelin receptors, thereby
promote neuroprotection of RGCs and their axons. A major highlight of the application is the development of
neuroprotective strategies using macitentan, a FDA approved drug, which has the potential to be rapidly
transitioned from the bench to the bedside for the treatment of glaucoma. This will greatly facilitate the
development of a neuroprotective treatment of glaucoma, which is much needed to slow down the progression
of visual impairment that occurs in some glaucoma patients, despite aggressively lowering IOP.

Public health relevance
Endothelin receptors are proteins that are increased in the eyes with increased pressure as seen in glaucoma. In the current grant application, the process by which endothelin receptors contribute to the damage to the optic nerve will be studied at the level of the nerve cells in the eye. Endothelin receptors blockers will be tested to determine if they could protect nerve cells in the eye from dying due to elevated ocular pressure, and this could aid in the development of a repurposed medication, macitentan, for glaucoma treatment.